Elucidating the Role of the Gut and Tumor Microbiome in Malignant Glioma

ABSTRACT/SUMMARY
Malignant gliomas, specifically glioblastoma (GBM), are highly aggressive, incurable brain tumors. Even with
maximal surgical resection, chemotherapy and radiation, tumor recurrence is absolute and median survival is
approximately 14 months. Immunotherapeutic strategies have had notable success in the management of
multiple solid malignancies. Unfortunately, immunotherapy, particularly checkpoint blockade, has had limited
success in the treatment of GBM due to its immunosuppressive microenvironment and multiple intrinsic immune
evasive mechanisms. Novel strategies to address local immunosuppression, augment the immune response
and enhance responsiveness to immunotherapies are warranted to improve patient outcome. The gut
microbiome is a well-established modulator of host immune responses. Microbiota-driven immunomodulation
has been demonstrated to impact responses to immunotherapy in multiple malignancies and interventions that
modulate the microbiome can enhance treatment response and improve patient outcome. In addition to the gut
microbiome, the intra-tumoral microbiome has also been demonstrated to impact patient response to
immunotherapy. The microbiome-gut-brain-axis is a known bidirectional pathway with extensive
immunomodulatory influence on the central nervous system (CNS) including a direct impact on the functionality
of microglia. Further the gut microbiome has also been implicated in the pathogenesis and progression of a
variety of neurological conditions. In addition to the gut microbiome, our own work and others have demonstrated
the presence of bacterial signatures in GBM patient samples, however the clinical impact of the GBM tumor
microbiome is unknown. Despite its pervasive influence, the role of the microbiome in CNS malignancies has
not been evaluated. We propose to address this gap in knowledge with a systematic, multi-platform evaluation
of the microbial composition GBM using prospectively collected clinical samples (tumor and gut/stool). We will
correlate these microbial signatures with both the immune composition of the GBM tumor microenvironment and
patient outcome measures. Further, we will compliment our clinical finding with preclinical, immunocompetent
GBM mouse model examining the impact of gut microbiome depletion on tumor growth and the tumor immune
microenvironment. Our hypothesis is that differential gut and tumor microbial signatures are present in GBM
patients, contribute to the tumor microenvironment composition and impact patient outcome. We will study this
via the following aims: AIM 1: Determine the gut and tumor microbiome signatures associated with improved
outcomes in patients with GBM. AIM 2: Determine the immunomodulatory role of the microbiome in GBM. If
successful, we will be the first to describe the role of the gut and tumor microbiome in malignant glioma. Our
long-term goal is to develop novel strategies to overcome therapeutic resistance and improve patient outcome.

Public health relevance
PROJECT NARRATIVE Glioblastoma (GBM) is the most common and deadly malignant brain tumor in adults and thus far has been resistant to immunotherapeutic strategies due to its immunosuppressive tumor microenvironment. The gut and tumor microbiome are known immune modulators and gut microbial composition as been demonstrated to significantly impact patient responses to immunotherapy in multiple solid malignances. This project will examine the impact of the microbiome (gut and tumor) on the immune composition of the GBM microenvironment and patient outcome.